Food is Medicine: Randomized Trial of Medically-Tailored Food Support for Diabetes Health

ABSTRACT
In the United States, 29.1 million persons live with type 2 diabetes mellitus (T2DM) and 49 million persons are
food-insecure, both disproportionately impacting low-income communities. Food insecurity is strongly associated
with the development of T2DM and, among people with T2DM, poor glycemic control, operating through
nutritional, mental health, and behavioral pathways. Existing nutrition safety-net resources are inadequate to
address the health effects of food insecurity. Policy makers increasingly recognize the premise that “Food is
Medicine” - i.e. that medically tailored food support for chronically ill, food-insecure people can play a critical role
in achieving optimal health outcomes. In collaboration with Project Open Hand, a large non-profit nutrition agency
that provides medically tailored meals and groceries to low-income, chronically ill residents of the San Francisco
Bay Area, we propose a randomized controlled trial (RCT) of Changing Health through Food Support for Diabetes
(CHEFS-DM). CHEFS-DM is a six-month intervention providing a DM-tailored diet meeting approximately 75%
of daily energy requirements and designed based on American Diabetes Association guidelines, together with
DM nutritional education provided by registered dieticians. In our pilot study, the intervention was feasible,
acceptable, and associated with improvements in food security, diet quality, health behaviors, mental health, and
trends towards improvements in acute care use and DM control. In this pragmatic RCT, we propose to rigorously
evaluate the intervention among 400 low-income adults with T2DM recruited from networks of safety net clinics
in San Francisco and Alameda counties, California. Leveraging POH's real-world programs, we will randomize
participants 1:1 to intervention and control arms, following all participants with surveys, blood pressure
measures, anthropometry, 24-hour recalls, medical record review and fasting blood draws at baseline and six
months to assess intervention impacts on health outcomes; intervention participants will complete an additional
twelve-month assessment to assess sustainability. In Aim 1, we will determine the impact of CHEFS-DM on
diabetes health, hypothesizing the intervention will improve hemoglobin A1c (primary outcome) and other
cardiometabolic outcomes [decreased fasting glucose, blood pressure (BP), lipids, acute care utilization, DM
medication intensification and increased health-related quality of life (HRQoL)] (secondary outcomes). In Aim 2,
we will use our published conceptual framework to understand the nutritional, mental, and behavioral paths
through which CHEFS-DM may impact T2DM health outcomes. Finally, in Aim 3, we will determine the cost-
effectiveness and sustainability of CHEFS-DM, and conduct a mixed-methods process evaluation to understand
intervention strengths and limitations to inform scale-up. We hypothesize that the intervention may be cost-
effective and possibly even cost saving, and that health benefits will be sustained after the intervention period.
Our ultimate goal is to help stop the cycle of food insecurity and diabetes-related morbidity and mortality,
consistent with the nutritional, DM-related and health disparities goals of US Healthy People 2020.

Public health relevance
PROJECT NARRATIVE Medically tailored food for chronically ill, food-insecure people may play a critical role in achieving optimal health outcomes for low-income individuals living with type 2 diabetes mellitus (T2DM) in the United States. Our multi- disciplinary team proposes to conduct a randomized controlled trial among 400 low-income individuals living with T2DM in the San Francisco Bay Area, California, to test the impact of providing diabetes-tailored food support and nutritional education on T2DM outcomes. This rigorous, community-based study will provide timely evidence on the efficacy of medically tailored food support for T2DM health to inform real-world implementation of “Food is Medicine” programs and policies, in line with NIH priorities for nutrition research.